Macrophage Circadian Clock Disruption and Inflammation in Heart Failure

Monocytes and macrophages fundamentally originating from the bone marrow and spleen - pro-inflammatory
Ly6Chi monocytes in mice (CD14hi cells in humans) and C-C chemokine receptor 2 (CCR2)+ monocyte-derived
macrophages (MDMs) - contribute importantly to tissue injury and left ventricular (LV) remodeling in chronic heart
failure (HF), suggesting that these cells may represent therapeutic targets for immunomodulation. Importantly,
monocytes and MDMs exhibit circadian variation in multiple functional parameters, in large part due to a robust
cell-autonomous molecular clock, which is regulated by the CLOCK/BMAL1 transcriptional complex and subject
to an autoregulatory loop involving Rev-erba. Notably, whether the intrinsic circadian clock in monocytes and
MDMs is disrupted in HF and its mechanistic link to inflammation and disease progression is entirely unknown.
Our pilot studies suggest that monocyte and MDM clock disruption is characteristic of HF, and that
monocyte/macrophage Bmal1 (and subsequent Rev-erba/b) loss is associated with upregulation of the immune
activator E4bp4, and aggravation of LV remodeling. Based on these data, we hypothesize that the
monocyte/MDM clock is dysfunctional in HF, leading to pathological inflammation and cardiac remodeling in a
REV-ERBa-linked and E4BP4-dependent manner, and that clock correction is a key molecular target for
immunomodulation. Three Aims will test this hypothesis. In Aim 1, we will define alterations in the monocyte
circadian clock in HF using a murine coronary ligation model, and test whether monocyte/macrophage clock
disruption in myeloid-specific Bmal1 knockout (MBK) mice exacerbates inflammation, innate immune expansion,
and LV remodeling during HF. We will also measure inflammatory and clock genes in CD14hi monocytes from
humans with HF. In Aim 2, we will delineate the role of monocyte-localized E4bp4, a clock-controlled
inflammatory transcription factor and direct target of Rev-erba, in HF by assessing inflammation and LV
remodeling after coronary ligation in myeloid-specific E4bp4 knockout (MEK) mice. We will also evaluate whether
monocyte E4BP4 suppression rescues the aggravated LV remodeling observed with monocyte/macrophage
clock disruption by inducing HF in myeloid-specific Bmal1/E4bp4 double knockout mice. In Aim 3, we will
mechanistically establish the potential of targeting the circadian clock as a therapeutic approach in HF, by testing
whether treatment with SR9009, a synthetic REV-ERBa/b agonist, favorably modulates monocytes and MDMs
and ameliorates or reverses LV remodeling in wild-type mice with established HF, and then in MEK HF mice to
determine whether the effects of SR9009 require monocyte/macrophage E4bp4. We will also evaluate the ex
vivo activation responses of human HF CD14hi monocytes to the agonist. These studies will further our
understanding of how changes in the macrophage circadian clock modulate both inflammation and disease
progression in HF, and test novel approaches to immunomodulation using genetic and pharmacological
strategies to correct the pathological changes induced by clock disruption.

Public health relevance
Relevance: Heart failure (HF), a progressive disease with a poor prognosis, is characterized by inflammation and the expansion and activation of tissue-injurious and pro-inflammatory monocytes and macrophages both globally and in the heart; however, the underlying reasons for (and therapeutic approaches to) modulate such heightened activity remain unclear. We will test a novel hypothesis for the pathogenesis of inflammation in HF - that it is driven primarily by disruption of the monocyte/macrophage molecular circadian clock that is responsible for the rhythmic regulation of their cellular machinery. We further propose that therapeutically targeting specific clock components (e.g., REV-ERB) or clock-controlled genes (e.g., E4bp4) represents a better approach to alleviating inflammation in HF.